Analysis of embryonic brain wiring in C. elegans

Analysis of embryonic brain wiring in C. elegans The goal of this project is to investigate how neural circuits are assembled in C. elegans embryos. We develop assays for an embryonic behavior (a sleep-like quiescent state) and for the neurons controlling this behavior. This embryonic sleep state is analogous to the quiescence that occurs during larval molts. We will determine if quiescence is triggered by cuticle synthesis. We will image synapse formation in embryos and will determine if sleep circuit development is controlled by heterochronic genes (which control larval skin development). We will also ask if circuit development is altered by mutations that prevent sleep or by those linked to Autism spectrum disorders (ASD). These Aims address basic questions about the genetic and physiological mechanisms controlling early brain development.

Public health relevance
Title: Analysis of embryonic brain wiring in C. elegans Narrative: We propose to analyze how functional neural circuits are assembled in embryos. These experiments will examine how early brain development is regulated and if it is altered in sleep and neurodevelopmental disorders.